Center of Biomedical Research Excellence in Cardiovascular Health Research Core

PROJECT SUMMARY/ABSTRACT
The goal of the University of Delaware Center of Biomedical Research Excellence in Cardiovascular Health is to
continue to support multidisciplinary research aimed toward understanding the mechanisms underlying the
causes and consequences of poor cardiovascular health and/or function, and developing effective interventions
for these conditions. During Phase I our COBRE Research Core acquired equipment and supported personnel
that was instrumental in the advancement of our project leaders to R01 funding. In addition to COBRE projects,
the core has also supported a number of other NIH funded projects through both access to equipment and
personnel. The COBRE Research Core includes a Cardiovascular Research Core (CVRC) that provides
instrumentation and personnel, biostatistical support, and bioimaging support through the Bio-Imaging Center.
The establishment of the CVRC in Phase I took advantage of the Cardiovascular Physiology Labs that had been
constructed at UD to facilitate cardiovascular research in the Health Sciences Complex. The core expanded its
footprint over the course of Phase I as the needs of investigators continued to grow. In Phase II the core will be
led by a new core director, will add personnel for the management of equipment and facilities, acquire additional
ultrasound imaging equipment and upgrade confocal microscopy capabilities in the Bio-imaging Center. The
proposed Phase II COBRE in Cardiovascular Health will capitalize on our success and momentum from Phase
I and the Research Core will continue to be the research hub of this COBRE accelerating the pace of
investigation in the center. The continued success and sustainability of the center depends on strengthening the
administrative framework and the infrastructure for the growing cardiovascular research at UD in order to support
project investigators and other investigators at UD.